IGF::OT::IGF - DELOITTE CONSULTING, LLP TO PROVIDE SUPPORT SERVICES FOR THE NHLBI INNOVATION AND COMMERCIALIZATION COORDINATING CENTER (NIC3).

SUPPORT SERVICES FOR THE NHLBI INNOVATION AND COMMERCIALIZATION COORDINATING CENTER (NIC3)